Characterization of a novel chimeric autoantigen receptor (CAAR) treatment for Graves' disease

Program Director/Principal Investigator (Last, First, Middle): Weber, K. Scott
Project Summary
Graves’ Disease (GD) is the fourth most common autoimmune disease in the United States, affecting ~6.5
million people, that primarily results in hyperthyroidism. The immunopathogenesis of the disease is initiated
by autoreactive B cells which secrete antibodies that bind to the thyroid stimulating hormone receptor
(TSHR). These anti-TSHR autoantibodies (TRAbs) are the critical cause of disease. They bind to TSHR on
thyroid cells, causing chronic stimulation and overproduction of thyroid hormones. Currently, there are no
treatments available to address the disease causing mechanism of GD, the TRAb producing B cells. The goal
of this research is to apply the concept of chimeric antigen receptor (CAR) T cell therapy to the development
of a novel and potentially curative treatment for GD. This will be done by generating a chimeric autoantigen
receptor (CAAR), which replaces the binding domain of a standard CAR with a fragment of the TSHR. The
TSHR fragment acts as bait for autoreactive B cells, because the B cell receptors (BCR) on their surface bind
to TSHR just as soluble TRAbs do. We have engineered TSHR CAAR T cells, and our preliminary data
show that the CAAR T cells bind to anti-TSHR Abs and B cell receptors, activate significantly, and can
specifically eliminate anti-TSHR B cells, but not other B cells. We will further characterize these GD CAAR
T cells by performing the following aims. 1) We will perform several cytotoxicity assays to determine the
efficacy of our CAAR T cells at eliminating anti-TSHR B cells while not harming other B cells. Flow
cytometry based cytotoxicity, proliferation, cytokine secretion assays, and a direct cytotoxicity assay will be
performed. 2) We will evaluate the influence of soluble TRAbs in GD patients that will likely bind to our
CAAR T cells, which could have an inhibitory or activating effect. We will perform cytotoxicity experiments
in the presence of physiologically relevant levels of commercially available TRAbs and GD patient serum.
We will also evaluate cytotoxicity in the presence of thyroid stimulating hormone to determine its possible
effect on the CAAR T cells. 3) We will develop a bispecific LINK CAAR to further increase the safety and
specificity of the treatment, by requiring binding to anti-TSHR BCR/Ab and a B cell marker, CD19, to initiate
the CAAR T cell cytotoxicity. These LINK CAAR T cells will be compared to our original CAAR T cells
for their efficiency, specificity, and ability to activate only on target. Thus, this project applies concepts of
CAR T cell therapy to the development of a novel and potentially curative immunotherapy treatment for
Graves’ disease.
Project Summary

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Weber, K. Scott Project Narrative In this project we will characterize a novel chimeric autoantigen receptor (CAAR) immunotherapy engineered to specifically bind to and remove the autoreactive B cells that cause Graves’ disease. CAAR T cell therapy could be a curative treatment for Graves’ Disease, which is needed because current treatments require lifelong treatment and hormone replacement and have unfavorable side effects. This work has broad relevance and potential applications for the development of immunotherapies for many autoimmune diseases, improving our understanding of the causes of autoimmune diseases, and the role of autoreactive antibodies on immune cell activation and function. Project Narrative